MADIVA (Multimorbidity in Africa: Digital innovation, visualisation and application)

Project summary – MADIVA: Multimorbidity in Africa: Digital
innovation, visualisation and application Research Hub
Our research hub will develop data science to address the complex interplay, individual and public health
challenges, and rising prevalence of multimorbidity in Africans. Epidemiological transition in Africa has
greatly changed health risks at both individual and public health levels. Trauma, infectious & non-
communicable diseases are major health challenges; multiple occurrences multiply burdens for individuals
and communities. The inherent value from the increasingly rich and varied existing data has not been
exploited. We have rich longitudinal epidemiological data sets, partial but increasingly available clinical and
laboratory records, and genomic data. The data, as is common in the domain, is highly heterogeneous, and in
parts, fragmented and incomplete.
The Hub will be led by the University of the Witwatersrand, Johannesburg collaborating with the African
Population and Health Research Center (Nairobi, Kenya), IBM Research Africa, the South African Population
Research Infrastructure Network and Vanderbilt University Medical Center. The initial sites are an urban
population in Nairobi, and a rural, transitioning, site in Bushbuckridge, South Africa: each has rich
longitudinal data of >100,000 individuals. Although incomplete, clinical records are increasingly being
captured digitally. Notably there is genomic data from a subset of individuals at each of the sites.
Multimorbidity is inherently multi-factorial — fragmented unlinked data retards solutions. Project 1 focuses
on linking. Integrated data sets will aid in understanding these communities, representative of many in Africa,
and protocols developed will be applicable elsewhere. A researcher dashboard will allow researchers to find
data and plan projects. A clinic dashboard will help clinic managers and health officials to monitor and plan
effectively. Project 2 will be solution-oriented to develop novel data science methods to provide actionable
insights. We will develop robust methods for risk profiling of individuals and communities using
heterogeneous data. We pioneer the use of polygenic risk scores in Africa. Key data science questions are
explicability of results and managing high-dimensional data without loss of power. An innovative aspect of
our grant will be translational work with public precision health to provide insights into drug dispensing,
pharmacogenomics, and behavioral or possible social interventions.
The Capacity Development & Pilot Project Core will support a tiered set of pilot projects for African
researchers at different career stages, leveraging our strong research platforms and networks. We aim to build
capacity in key areas including incubation and cost modelling for data science. The Administrative and
Leadership Core will provide the necessary leadership and project management and linking to other DS-I
components. The Data Management and Analysis Core will develop protocols for the responsible sharing of
data, data quality control, technical support as well as innovate new analysis techniques.

Public health relevance
The MADIVA Research Hub will develop data science techniques and solutions to tackle the problem of multimorbidity in Africa – the problem of multiple co-occurring diseases significantly adding to the health burden in Africa. Our primary research sites in rural Bushbuckridge, South Africa and urban Nairobi, Kenya each have rich data sets from longitudinal studies collected by the health and demographic surveillance systems based there, together with a nascent set of clinical health records and genomic data. We will develop and apply data science techniques to link the different data sets, build dashboards for different stakeholders and apply new machine learning techniques to automatically stratify populations for risk profiles to different diseases, including the use of polygenic risk scores.